Stanford University Regional Coordinating Stroke Center for the NIH Stroke Trials Network

PROJECT SUMMARY
The Stanford Stroke Center, one of the first comprehensive multidisciplinary centers of its kind, was established
in 1992 to develop new approaches to diagnose and treat stroke. The mission of the Stroke Center is to be the
best comprehensive organization in the United States focused on stroke diagnosis, treatment, research, and
education. In 1992, the Center was established by a team of neurologists, neurosurgeons, neuroradiologists,
nurse specialists, basic scientists, and clinical researchers. This multi-disciplinary team has met regularly to
continually refine the program for 30 years. In 2012, the Joint Commission and the American Heart
Association/American Stroke Association announced that the Stanford Stroke Center was the first hospital in the
United States to meet The Joint Commission's standards for Disease-Specific Care Comprehensive Stroke
Center Certification.
Stanford was chosen to be one of the original StrokeNet Regional Coordinating Centers (RCCs). During the past
10 years, one of Stanford’s major contributions to the network included the development of the DEFUSE 3 study,
which became the first clinical trial to be funded and executed by StrokeNet and which changed stroke practice
guidelines and clinical practice around the world. In addition, Stanford’s regional network is one of the highest
enrollers in StrokeNet studies and Stanford faculty have made major contributions to key StrokeNet committees.
The Stanford-RCC remains fully committed to continue to provide high volume enrollment of diverse patient
populations into NINDS funded stroke trials during the transition period between the end of the current StrokeNet
segment and the new segment. The Stanford RCC has selected the next StrokeNet trainee and will continue to
offer an innovative multidisciplinary fellowship program that provides comprehensive training in clinical trial
design, implementation and analysis.

Public health relevance
PROJECT NARRATIVE The Stanford Stroke Center has developed a comprehensive stroke network consisting of Stanford Healthcare, Stanford Lucile Packard Children’s Hospital and 5 additional regional stroke centers that provide a high volume of patient enrollment into NINDS funded stroke trials. The Stanford Regional Coordinating Center team has been an active partner in and major contributor to the StrokeNet initiative for the past 10 years and commits to remain fully engaged in all StrokeNet activities during the supplemental funding period. Project Narrative Page 7